Genomics & Epigenomics Shared Resource

GENOMICS & EPIGENOMICS SHARED RESOURCE: PROJECT SUMMARY
“Omics” technologies emerged relatively recently and evolved rapidly, becoming essential to almost every aspect
of cancer research. In view of this, the Genomics & Epigenomics Shared Resource (GESR) is an indispensable
Shared Resource for the Georgetown Lombardi Comprehensive Cancer Center (LCCC) and serves Center
Members on both the DC and NJ campuses. The objective of the GESR is to provide investigators with diverse,
state-of-the-art services for genomic and epigenomic studies, such as DNA/RNA quality assessment, mRNA
expression profiling, miRNA expression profiling, DNA sequencing, single-nucleotide polymorphism (SNP)
genotyping, copy number variation (CNV) analysis, DNA methylation analysis and label-free molecular interaction
analysis. The GESR uses a variety of platforms for these services, including bioanalyzer, microarray, next-
generation sequencing (NGS), real-time–polymerase chain reaction (RT-PCR), count-based expression analysis
(NanoString), and surface plasmon resonance (SPR). To facilitate these services, the GESR organizes education
and training on emerging technologies and provides bioinformatics support and access to software tools and
several user-operated instruments. GESR is co-directed by Habtom Ressom, PhD, Aykut Üren, MD, and Benjamin
Tycko, MD, PhD. The GESR also relies heavily on the input from the GESR Advisory Committee (AC) and user
surveys to prioritize development and assess programmatic needs across the consortium. To this end, new
services such as single-cell RNA-seq, digital spatial profiling, and targeted methyl-seq have been launched since
the last submission. In FY2022, the GESR provided services to 33 LCCC Members across all three Research
Programs (19 Cancer Cell Biology Members, 11 Cancer Host Interactions Members, and 3 Cancer Prevention
and Control Members). During the current project period, the GESR supported basic science and translation
research with 37 publications, including 12 manuscripts published in high-impact (IF > 10) journals such as
Oncogene, Cell Death Differ, Dev Cell, Clin Cancer Res, and Gastroenterology, and provided critical support
that enabled the success of 53 extramurally-funded research project grants, and 4 clinical trials. In summary,
state-of-the-art instruments housed in the GESR and high-quality services offered by the GESR contribute to
numerous, high-impact collaborative research projects among LCCC Members.